Core B: Qunatitative Analysis and Proteomics Core to Detect S-Nitrosylation

The mission of this Quantitative Analysis and Proteomics Core (QAPC) will be to provide comprehensive proteomic approaches for the individual projects of this NIEHS Center to detect and characterize PD-related proteins, especially with regard to S-nitrosylation (reaction of the NO group with critical cysteine thiol to regulate protein function) and further oxidation reactions. Core B will support the efforts of Project 1, Project 2, and Project 3 by analysis and quantification of PDrelated proteins and their possible S-nitrosylation (including SNO-parkin, SNO-DJ-1, and SNOprotein disulfide isomerase [SNO-PDI]) using multiple chemical and proteomic approaches. Core B will also support the efforts of Project 4 by detecting possible biomarkers represented by these SNO-proteins in a-synuclein-over-expressing or mitochondrial complex I inhibitor-treated in hESCderived neuronal cell models. This Core will also interact with Core E (High-throughput Chemical Library Screening) by providing DAN assays that detect S-nitrosylated proteins in 384- and 1536- well multiwell formats in order to screen for small molecules that prevent S-nitrosylation of PDrelated proteins such as parkin, DJ-1 and PDI. These small molecules will then be tested for neuroprotection in PD model systems in Projects 2, 3, and 4.